Enhancing the Kids First Platform’s Support for Collaborative Programs and Community Engagement

Project Summary
The Kids First DRC and associated platforms continue to advance support for the Kids First Program as well
as leverage new technologies to support pediatric data interoperability across NIH programs and advance the
use of the scaled data resources of the KF program. The proposed supplement focuses on advancing the KF
DRC’s support of the CARING for Children with COVID data, the advancement of FHIR-based resources for
maternal and child health, and enhanced outreach activities via conferences and meetings on behalf of the
program’s growing resources. The proposed activities build on and enhance the existing programmatic
resources and workflows established by the KF DRC.

Public health relevance
Project Narrative The Kids First DRC and associated platforms advance support for the Kids First Program through new technologies that enhance support pediatric data interoperability and the data’s enhanced impact on behalf of alleviating the suffering of children affected by disease. Through the proposed supplementary support the Kids First DRC will further enhance the required resources to support pediatric COVID data and FHIR-based resources for maternal and child health on behalf of researchers. Additionally, the DRC will engaged in enhanced outreach activities at conferences and meetings to support the program’s growing resources.